Preoperative exercise therapy modulates hepatic neutrophil extracellular trap formation

PROJECT DESCRIPTION: The goal of this Supplement application is to support a Baccalaureate’s degree
holder from underrepresented minority group, for pursuing a career in biomedical research. The candidate will
receive personized mentorship and support to enhance her medical research experience and experimental
skills to determine the mechanism by which preoperative exercise therapy modulates the capability of
neutrophils forming neutrophil extracellular traps (NETs), which is highly relevant to the parent grant
(R01GM137203) entitled "Preoperative exercise therapy for surgery triggered inflammation". Liver ischemia
and reperfusion (I/R) is an unavoidable consequence of major liver resection and liver transplantation that
leads to significant morbidity, mortality, and costs after liver surgery. However, previous strategies to protect
the liver from I/R injury have focused on one specific known injury mechanisms, leaving intact other detrimental
processes. Pre/post-operative exercise facilitates recovery after major abdominal surgery. It is known that
exercise confers beneficial effects on the surgical outcome by regulating multiple mechanisms, including
alteration of quantity and function of innate immune cells to provide an anti-inflammatory environment. We
have discovered that preoperative exercise therapy (PET) significantly reduced serum aminotransferase levels
(liver damage) and expression of cytokines and chemokines (inflammatory responses) during liver I/R via
metabolic reprogramming Kupffer cells from pro-inflammatory to anti-inflammatory phenotype. However, even
though cellular energy metabolism and mitochondrial biogenesis play a critical role in the immune response,
the effects of PET-induced changes in neutrophils forming neutrophil extracellular traps (NETs) have never
been studied. The undergraduate summer research program at Feinstein Institutes for Medical Research is a
well-established research program that support undergraduate students who are considering pursuing
biomedical research careers in cutting-edge scientific environments during the summer. Our proposed studies
which will be conducted by undergraduate student will significantly expand the scope of the parent R01 award
by interrogating two new questions related to those already being investigated in the parent R01 award: 1)
What is the role of PET in the transcriptomic changes of infiltrating neutrophils after liver I/R? 2) Do PET-
trained KCs suppress NET formation during liver I/R? In summary, the mentored studies will provide valuable
training and mentorship to the candidate, contributing to her career development and increasing diversity in
biomedical research and will significantly expand the current understanding of the underlying mechanistic
mechanisms by which PET prevent surgical stress-induced organ injury via modulating NET formation and
evaluate novel potential therapeutic targets, and assess promising novel treatments for patients undergoing
surgery.

Public health relevance
Project Narrative Preoperative exercise therapy (PET) is a highly applicable non-pharmacological-based therapy and has successfully reduced postoperative complications and conferred better recovery from major liver surgery. This project will determine the mechanisms by which PET prevents liver ischemia/reperfusion injury which is an unavoidable consequence of major liver surgery by altering the trained immunity in hepatic resident macrophages (Kupffer cells), and the NET-induced local and systemic inflammatory response. The finding from this proposal will provide the knowledge foundation for not only optimizing the development of PET against surgery-induced organ injury but also devising exercise-mimicking pharmacological strategies for patients who are exercise intolerant.